The University of Miami AIDS Research Center on Mental Health and HIV/AIDS - Center for HIV & Research in Mental Health (CHARM)

PROJECT SUMMARY: ADMINISTRATIVE CORE (A)
The Administrative (Admin) Core in the Center for HIV and Research in Mental Health (CHARM) acts as
our primary organizational hub. It is responsible for administratively assisting Core leaders, investigators, and
other users, so that the Cores can focus on scientific activities directed to achieving their Aims. This allows
CHARM to be an institutional, regional, and national resource for HIV-related mental health (MH) disparities
research across the HIV prevention and care continua.
The proposed Admin Core builds on our successes achieved during the current Developmental Center
funding period. We initiated and iteratively refined all organizational and Center-structure activities, such as
establishing and focusing the successful and efficient organizational structure of which Core is responsible for
what activities, coordinating the advisory boards (Internal, External Scientific, and Community), managing
ongoing strategic planning and iterative synergy across the Cores, optimizing the use of existing resources,
and creating a positive collaborative research environment for multi-disciplinary HIV/AIDS MH research. We re-
ignited and re-invigorated supportive MH HIV/AIDS research at UM, facilitating the submission and attainment
of external grant proposals including 9 competitive Federal End-the-Epidemic (EHE) supplements and one
administrative supplement, became an official University-wide designated Center, set up the developmental
award reviews and pre-award initiation of projects.
As a Full Center, The Admin Core in CHARM will continue to provide the umbrella organizational
structure for the Center and its Cores. We will continue to support scientific growth by assisting the
Developmental and three Research Cores with their Aims; managing overall Center and supplement finances,
reporting, and regulatory requirements; and monitoring Core activities to ensure progress toward the Center’s
short-term objectives and long-term goals. The Admin Core assists with organizing meetings (e.g., Research
in Progress reviews, and cross-Core and Center-Center meetings at UM). The Core facilitates weekly
meetings with the Coordinators of all 5 Cores and the Center Executive Director, monitors Core progress (for
ongoing evaluation / goal attainment, and for reporting to the advisory boards as well as NIH progress reports),
and, through the Admin Core, Center leadership ensures dynamic strategic planning, working closely with
three advisory groups (Internal Advisory Board, External Scientific Advisory Board, and the CAB) and
monitoring enactment of their recommendations. In the Developmental funding period, the Core achieved its
overarching goal to provide sufficient administrative support to the Center leaders, the CAB, the Cores, and the
users to ignite MH HIV/AIDS scientific areas of highest priority in our community in the Greater Miami area. We
will continue to build from this now that we have a highly functioning administrative and organization structure
in place that was initiated during the developmental funding period.

Public health relevance
Project Narrative for Other Components Please see Overall Component for Project Narrative.